Ethanol effects on GABA-serotonin interactions in the Dorsal Raphe Nucleus

DESCRIPTION (provided by applicant): Alcohol dependence is a serious disorder for which effective treatments are lacking. Dysregulation of the serotonin system has been widely implicated in alcohol dependence though little is known about chronic ethanol's effects on serotonin neurons themselves or the microcircuit to which they belong. In the dorsal raphe (DR), a midbrain structure from which 50% of the brain's serotonin arises, serotonin neuron activity is modulated by local GABA neurons. The effects of chronic ethanol on GABA neurons of the DR and their modulation of serotonin neuron activity have not been explored to date. Using whole-cell slice electrophysiology, chronic ethanol vapor exposure, behavioral, optogenetic and chemogenetic approaches, the goal of this proposal is to test the hypothesis that chronic ethanol induces adaptations in GABA neuron function within the DR, resulting in altered modulation of serotonin neuron activity. The results of the proposed experiments will provide insight into the role of DR GABA neurons in dysregulated serotonin activity resulting from chronic ethanol exposure and will inform the development of pharmacotherapies targeting the serotonin system for the treatment of alcoholism.

Public health relevance
PROJECT NARRATIVE Chronic alcohol use is a pervasive health concern that involves adaptations in both the serotonin and GABA systems of the brain. GABA modulates serotonin neuron activity in the dorsal raphe (DR), a major serotonergic nucleus of the mibrain. This proposal will use a mouse model of chronic ethanol exposure, whole-cell slice electrophysiology, optogenetic, chemicogenetic and behavioral approaches to explore the hypothesis that adaptations in DR GABA neuron function following chronic ethanol exposure leads to dysregulated serotonin neuron activity in the DR.